Molecular Tailoring of Bispecific Antibody–BottlebrushConjugates

Bispecific antibodies (bsAbs) have emerged as a transformative class of biologic therapeutics that enable
targeting of multiple antigens or pathways, generating potent and highly selective therapeutic responses.
Despite significant advances in bsAb formats, the overall tunability of bsAb structure remains limited and the
impact of spatial configuration between binding sites, e.g., distance and orientation, on efficacy remains
underexplored. We hypothesize that optimal targeting of different antigens within the same or multiple cell
types will depend on the inter-binding-domain distances between antibody components of bsAbs. Testing this
hypothesis requires a new synthetic route to bsABC-like molecules with controlled, rigid spacing between two
antibody binding domains, which could be achieved by linking together two antibodies with a rigid
macromolecular “ruler.” This project aims to develop synthetic methods to access such systems, using
bottlebrush polymer s(BPs) as the rulers for constructing bsAbs with defined lengths and access to length
scales not possible with traditional bsAbs. By leveraging single-chain variable fragment (scFv) technology,
precise polymerization, and advanced conjugation techniques, a family of bispecific “Antibody–Bottlebrush
Conjugates (bsABCs) will be synthesized, incorporating adjustable bottlebrush scaffolds and scFv species to
investigate the effects of inter-antigen distance and targeting specificity on cell targeting and immune
recruitment. Variables such as ABC length and aspect ratio will be tuned to identify their impacts on cell
binding and activation using a suite of in vitro assays. Additionally, synthetic methods for installing small
molecule imaging fluorophore into the bottlebrush domains of bsABCs will be developed; these fluorophores
will enable imagining of bsABC cellular uptake and their syntheses will provide guidelines for future drug-
carrying bsABCs. Finally, building on these learnings, a synthetic strategy for accessing trispecific antibody–
bottlebrush conjugates (tsABCs) is proposed, wherein three unique binding domains from antibodies are linked
together through a macromolecular core. Comprehensive in vitro studies will evaluate the impacts of molecular
structure on the function of bsABCs and tsABCs, deepening the understanding of the importance of spatial
configuration in multi-functional antibody–conjugate design and providing design principles for bsAb formats in
future clinical applications. It is expected that precise control over antibody architecture and structure will
improve pharmacokinetics, reduce dosing requirements, and enhance T cell-tumor cell interactions, ultimately
leading to safer and more effective disease treatments.

Public health relevance
This project aims to invent synthetic methods for the preparation of novel multi-functional antibody conjugates using molecular bottlebrush polymers as scaffolds. By establishing a versatile synthetic platform for such structures, we seek to uncover design principles and structure-function relationships that will guide the future design of bi- and tri-specific antibodies. The results will the pave the way for safer, more effective multifunctional antibody therapeutics with functions not possible with current bispecific antibody formats.